Androgen receptor pathway inhibition through targeting PARP-2 in castration-resistant prostate cancer

ABSTRACT
Androgen receptor (AR) is ligand-activated transcription factor and a driver of prostate cancer (PCa).
Understanding the molecular mechanisms of AR-mediated transcription is a key for the development of novel
therapeutic strategies for both castration-sensitive prostate cancer (CSPC) and castration-resistant prostate
cancer (CRPC). It is well-known that AR transcriptional activity is prominently dictated by the transcription
activator FOXA1, which acts as a ‘pioneer’ factor opening the condensed chromatin and facilitating the
recruitment of AR. Genome sequencing studies have revealed that FOXA1 is one of the most frequently
mutated genes in primary PCa and even more common in metastatic CRPC. Aberrant FOXA1 function is
implicated in PCa development and progression likely through its impact on AR signaling. Therefore, inhibition
of AR through targeting FOXA1 is a promising therapeutic approach for CRPC. However, to date FOXA1 has
been deemed undruggable. We recently reported that critical to the function of FOXA1 is its modulation by
poly-(ADP-ribose) polymerase 2 (PARP-2), conventionally known as a DNA repair protein. Our studies have
demonstrated that PARP-2 is a critical component in AR signaling through interacting with FOXA1 and
facilitating AR recruitment to prostate-specific enhancers. Expression of PARP-2 is significantly elevated in
primary PCa tumors compared to benign prostate tissues, and even higher in CRPC tumors. Selective
targeting of PARP-2 by genetic or pharmacological means blocks PARP-2/FOXA1 interaction, which in turn
attenuates AR-mediated gene expression and PCa growth. These results lead us to the hypothesis that PARP-
2 plays a central role in AR-mediated transcription through interacting with FOXA1. Therefore, PARP-2
Inhibition attenuates AR signaling through disrupting FOXA1 function, which provides an alternative
therapeutic strategy for AR inhibition without involving AR ligand binding.
The overall objective of this project is to determine the molecular mechanisms by which selective targeting
of PARP-2 inhibits CRPC growth through disruption of FOXA1 function and define PARP-2 as an alternative
therapeutic target for CRPC. To attain the overall objective, we propose two specific aims: Aim 1: Determine
the molecular mechanisms by which targeting the PARP-2/FOXA1 interaction inhibits AR signaling. Aim 2:
Determine to what extent selective targeting of PARP-2 inhibits CRPC tumor growth in preclinical models. The
successful implementation of this project will greatly advance our understanding of multifaceted biology of
PARP proteins and their evolving impact on cancer therapeutics. More specifically, the results from the
proposed research are expected to provide a strong basis for future development and clinical application of
selective PARP-2 inhibitors benefiting patients with incurable metastatic CRPC.

Public health relevance
PROJECT NARRATIVE PARP-2 is a critical component in androgen receptor signaling through interacting with FOXA1. Selective targeting of PARP-2 blocks the PARP-2/FOXA1 interaction, which in turn inhibits androgen receptor-mediated gene expression and prostate cancer growth. In this project, we will define PARP-2 as a therapeutic target in castration-resistant prostate cancer.